VARIOUS CYTOTOXIC DRUG PROGRAMS IN DIFFUSE LUPUS NEPHRITIS

Eighty-two patients have been randomized to receive. The study is closed to participants. Rate of progression to renal failure, requirements for re-treatment, and drug toxicities are being assessed.